Haplotype-aware models of gene and isoform expression with application to genetic studies of disease in diverse populations

Project summary/abstract Recent major efforts have generated genome sequencing data from large-scale biobanks, including the UK Biobank, Vanderbilt BioVU, TOPMed program, and others. These new data provide a rich environment for the analysis of rare genetic variants in human populations, especially those uncommon in European ancestry populations. However, the sheer scale of the data generated by sequencing poses a limitation for their analysis. This proposal requests a one-time administrative supplement to establish the necessary infrastructure for integrative analysis of primary genome sequencing data from multiple large genomic biobanks.

Public health relevance
Project narrative We will establish the computing infrastructure necessary for integrative analysis of primary sequencing data from multiple large genomic biobanks to improve haplotype-aware analysis of rare genetic variants, especially those uncommon in European ancestry populations.